Social environment determines the hedonice value of nicotine via molecular and cellular networks in the amygdala

Nicotine addiction is a major public health concern, causing over 480,000 deaths annually in the United States.
Despite its addictive properties, initial nicotine exposure in nonsmokers is usually aversive. The initiation of
smoking is heavily influenced by social factors, particularly during adolescence. We developed a rat model,
Socially Acquired Nicotine Intravenous Self-Administration (SANSA), that simulates the initial negative
experience of voluntary nicotine exposure in adolescent rats and observed strong social influence in continued
nicotine intake despite this learned negative hedonic value. SANSA employs licking as an operant response to
trigger the simultaneous delivery of an oral flavor cue and intravenous (i.v.) nicotine. Adolescent rats tested
alone, or in the presence of another rat that does not have access to the flavor cue, develop a conditioned
flavor aversion (CFA) that inhibits further intake. In contrast, when the companion rat is also consuming the
flavor cue, stable nicotine self-administration is established. Remarkably, SANSA facilitates stable i.v. nicotine
self-administration even when an inherently aversive flavor cue is used. We hypothesize that social learning
alters nicotine's hedonic value by facilitating the extinction of nicotine-conditioned aversion. Specifically, we
propose that the Cacna1c gene, which encodes the Cav1.2 protein and is associated with smoking initiation in
human GWAS, and the oxytocin receptor (Oxtr) are critical to this effect, mediated by their interactions in
central amygdala (CeA) GABAergic neurons. We will test this via three Specific Aims. Aim 1 focuses on the
Cacna1c gene. Using heterozygous rats, we will study the role of Cacna1c in SANSA and the extinction of
nicotine CFA mediated by social learning. We will identify additional brain regions activated during social
learning and use single-nucleus RNA sequencing (snRNA-seq) to identify transcriptomic changes in the CeA.
saCas9-mediated genome editing will selectively knock out Cacna1c in the CeA to provide further support for
our hypothesis. Aim 2 focuses on oxytocin signaling in the CeA in modulating SANSA. We will use optogenetic
manipulation to control oxytocin release and fiber photometry to monitor real-time neural activity during
SANSA. Aim 3 examines interactions between oxytocin and Cav1.2 in CeA GABAergic neurons. We will use
RNA-scope to visualize oxytocin receptor and Cacna1c in GABAergic neurons and use electrophysiological
recordings to investigate changes in neuron activity in response to oxytocin signaling. The multidisciplinary
data collected from this study will significantly enhance our understanding of smoking initiation and provide
valuable insights into the processes invoked by the social environment to influence the trajectory of SUD.

Public health relevance
Nicotine addiction is a leading cause of preventable disease and death, affecting millions worldwide. This research uses a rat model to uncover how genes associated with smoking initiation in humans contribute to initial voluntary nicotine consumption in a social context. Findings from this study will deepen our understanding of the molecular and neural mechanisms determining the trajectory of substance use disorders and have implications for public health policies in reducing smoking, especially among adolescents.